Role of the hepatic GABA shunt in insulin resistance and hyperinsulinemia

Abstract: The severity and incidence of T2DM is directly related to hepatic lipid concentration. Even before β-
cell failure ensues, the severity of non-alcoholic fatty liver disease (NAFLD) is positively associated with
hyperinsulinemia and insulin resistance. The hepatic vagal nerve plays a key role in glucose homeostasis
affecting both pancreatic insulin release and insulin sensitivity. Acutely eliminating hepatic afferent signaling
stimulates insulin release and decreases skeletal muscle glucose clearance, simultaneously resulting in
hyperinsulinemia and insulin resistance. Conversely, acutely stimulating the hepatic afferent nerve inhibits insulin
release and improves glucose clearance. Until recently there was no evidence for a hepatokine that signaled to
the vagal nerve to alter glucose homeostasis. We have established that hepatic lipid accumulation dose-
dependently increases hepatic production and release of γ-aminobutyric acid (GABA), an inhibitory
neurotransmitter. Our data proposes that hepatocyte produced GABA stimulates insulin release and decrease
skeletal muscle glucose clearance by altering activity of the hepatic vagal nerve. To establish therapeutic
potential, we have shown that liver GABA transaminase knockdown decreases liver GABA release, restoring
insulin sensitivity and normo-insulinemia in diet-induced obese mice. Through clinical trials, we have highlighted
the translational impact of potentially targeting hepatic GABA signaling. In clinical samples, we have shown that
hepatic GABA-transaminase mRNA expression is positively correlated with serum insulin and HOMA-IR. In
these same clinical samples, we have shown that glucose disposal during a hyperinsulinemic euglycemic clamp
is positively associated with mRNA expression of GABA re-uptake transporters and negatively associated with
mRNA expression of GABA exporters. We propose 3 Aims focused on our central hypothesis that GABA is a
hepatokine that can help explain the link between hepatic lipid accumulation and hyperinsulinemia and insulin
resistance in obesity.
Aim 1: Assess how obesity, lipids, diacylglycerol, ceramides, and downstream signaling affect direction
of flux through the GABA shunt and transport of GABA across the plasma membrane.
Aim 2: Assess the glucoregulatory response to exacerbating hepatic GABA production in lean mice or
limiting hepatic GABA production in obese mice.
Aim 3: Assess the glucoregulatory response to knockout (loss) and adenoviral induced overexpression
(gain) of hepatic GABA transporters in lean and diet-induced obese mice.
Impact: Validation of GABA as a novel hepatokine that affects serum insulin and insulin sensitivity in obesity
will provide new therapeutic targets to treat this disease.

Public health relevance
Project Narrative: The severity of non-alcoholic fatty liver disease is positively associated with hyperinsulinemia and insulin resistance. The hepatic vagal nerve provides a conduit by which the liver can communicate to affect insulin release and insulin sensitivity. We propose 3 Aims focused on our central hypothesis that GABA is a hepatokine that can help explain the how hepatic lipid accumulation alters vagal nerve activity to affect hyperinsulinemia and insulin resistance in obesity.